MAKE READY THE NIH BABY TOOLBOX FOR END USERS: FINALIZE ALL PARTICIPANT-LEVEL DATA COLLECTION, ANALYSES, AND DISSEMINATION

There is a wide range of early developmental assessment or screening instruments. Standardized, reliable assessment instruments (e.g., Bayley Scales of Infant and Toddler Development, Mullen Scales of Early Learning, Brigance Inventory of Early Development, Battelle Developmental Inventory, etc.) allow for direct evaluation of infant/child behaviors but they are time intensive, expensive to purchase, require highly trained personnel for administration, scoring, and interpreting, and often rely on outdated norms.
The purpose of the NIH Baby Toolbox” [NBT]) (previously known as the NIH Infant and Toddler Toolbox) “is to develop and nationally norm an easy to administer, score, and interpret infant and toddler assessment inventory of cognition, social functioning, language (receptive and expressive), numeracy, self-regulation, executive function, and motor function for research and clinical use in children between 1- to 42-months of age that will include direct child assessment (preferred measurement), supplemented as needed by parental/legal guardian report.
This contract is to support finalize all participant-level data collection, analyses, and dissemination, and to complete the NIH Baby Toolbox app/tool ready for use by research and clinical scientist end users.